GHES - NIEHS - Anafo

PROGRAM SUMMARY
The objective of our LAUNCH program is to continue our global health research training program called the
Global Health Equity Scholars (GHES) designed to create a new community of researchers, educators, and
professionals who are prepared to address new and emerging global health challenges. We will build on the last
nine years of this training program to create a cadre of new researchers who will dedicate their research careers
to address the health problems that arise out of the inequity of human conditions prevalent in informal human
settlements (slums). Rather than addressing one disease at a time, we propose to provide a comprehensive,
multidisciplinary, and integrated approach to deal with urban and rural informal human settlement health issues,
developed over many years by the participating faculty members of this program. This program will comprise
four US partner institutions (Consortium) - Yale University, Stanford University, University of Arizona, and
University of California at Berkeley, each led by a leader in global health research with more than 10 years of
collaboration among themselves. Together, core faculty mentors from these institutions conduct research at 25
institutions in 21 countries, representing regions of Africa, Central and South America, the Caribbean, Asia, the
Pacific, and Eastern Europe. The GHES program will address a wide range of health research topics including
HIV/AIDs, emerging and high-consequence infectiousdiseases, non-communicable diseases (NCDs), women's
health, environmental health, mental health, interpersonal violence, substance abuse, injuries, and the
interaction of all of these health issues within the framework of slum health. Training will target US postdoctoral
fellows and pre-doctoral students and low and middle-income country (LMIC) postdoctoral fellows. We plan to
recruit 9-10 trainees/year with 60% of them as US postdoctoral fellows. The trainees will spend 10-12-months at
an LMIC site under the supervision of the Consortium and their collaborating LMIC mentors. Didactic workshops
on global health research methods will be conducted both in-person and online. LMIC trainees will spend 2-3
months at US institutionsto undergo training in methods not provided at their institutions. All of the trainees will
be provided with research and career mentorship throughout their training and tracked for career development
after completion of their GHES-supported research work. Thus, under this program, we expect the trainees to
be exposed to one important theme in global health research - health equity - through research that deals with
health concerns of vulnerable populations residing in informal human settlements and provide them with an
opportunity to become experts in this new global health discipline. The overall impact of this training program is,
therefore, to create a new cadre of global health researchers and leaders who address the emerging health
issues arising out of ever-expanding informal human settlements of LMICs.

Public health relevance
PROGRAM NARRATIVE This training program is specifically designed to train a new cadre of researchers and leaders to address major but as yet under-studied public health problems engendered by conditions prevalent in urban and rural informal human settlements (slums) of low and middle-income countries (LMIC). This training is relevant also to developed countries as informal settlements in the form of homeless encampments expand. Selected candidates will undergo field training on site in LMICs to develop new global health research skills framed within our project research theme of health equity.